Targeting the apoE/A-beta Interaction as a Therapeutic Approach for AD

Alleles of the apolipoprotein (apo) E gene are by far the strongest identified genetic risk factor modulating susceptibility to sporadic Alzheimer's disease (AD) and the burden of β-amyloid (Aβ) deposition in the brain following the rank order of ε4>>ε3>ε2. Encoded by these alleles, apoE isoforms differ structurally and functionally but all bind in vitro synthetic Aβ peptide promoting its β-sheet folding and fibrillar assembly. Knockout (KO) of the Apoe gene in APP transgenic (Tg) mice prevents formation of fibrillar Aβ plaques and vascular deposits, confirming a critical role for apoE as a catalyst of Aβ deposition in vivo. In the current period of this award we developed APPSW/PS1dE9/apoE-TR mice (APP/E-TR) with targeted replacement (TR) of the mouse Apoe gene with various human APOE alleles, which faithfully reproduce the differential effect of apoE isoforms on the magnitude of Aβ deposition. We showed that systemic treatment of APP/E2 and APP/E4 mice with Aβ12-28P, which is a brain permeable synthetic peptide that binds apoE and prevents apoE/Aβ interaction, lowers Aβ deposition and level of toxic Aβ oligomers and attenuates neuritic degeneration in both lines of mice. This observation suggests a notion that targeting the apoE/Aβ interaction could reduce Aβ deposition in carriers of all types of APOE alleles. Development of apoE/Aβ antagonists for possible clinical application remains however problematic since neither the Aβ binding domain on apoE nor the structure of Aβ “super epitope” within its 12-28 sequence responsible for apoE interaction are presently known. In addition to catalyzing deposition of fibrillar Aβ, apoE isoforms also show differential effect on the clearance of soluble Aβ from the brain interstitial space, modulate microglia response and synaptic plasticity. Modus operandi of apoE on the clearance of Aβ from the interstitial fluid (ISF) remains elusive. Our preliminary microdialysis work indicates substantial interaction between apoE and soluble Aβ in the brain ISF, and suggests that apoE/Aβ antagonists may enhance soluble Aβ clearance and prevent Aβ oligomerization. This indicates potential for targeting the apoE/Aβ interaction as a disease preventive measure. In addition, systemic treatment of APP and APP/E-TR mice with Aβ12-28P reduces amyloid angiopathy and perivascular microhemorrhages and attenuates microglia activation, which suggests that combining an apoE/Aβ antagonist with anti-Aβ passive immunization could temper chronic inflammation and vasculotropic complications produced by the latter, while having synergistic outcome on Aβ reduction. The specific aims are: 1) To identify the Aβ binding domain on apoE and characterize its variability across apoE isoforms and to determine the structure of Aβ super epitope for apoE interaction. 2) To investigate how apoE isoforms differentially modulate soluble Aβ metabolism in the ISF and to study how targeting apoE/Aβ interaction improves Aβ clearance and attenuates its oligomerization. 3) To investigate whether combining apoE/Aβ targeting with anti-Aβ passive immunization would provide amplified therapeutic response and reduce the rate of adverse vascular events in APP/E-TR mice.

Public health relevance
Project narrative This project investigates how interaction between Aβ and isoforms of human apoE differentially modulates Aβ metabolism and affects susceptibility to Alzheimer's disease. It also studies targeting the apoE/Aβ interaction as a therapeutic approach for Alzheimer's prevention and treatment.